Impact of Dolutegravir on Viral Suppression, Retention, and Risk of Non-Communicable Diseases among Persons Living with HIV in South Africa.

Project Summary
South Africa has the world’s largest burden of HIV, with almost eight million people living with HIV and the
largest HIV treatment program in the world. With the ongoing development of new and more effective
antiretroviral therapies (ART), it is important to understand the effect of different treatment strategies on
treatment and care outcomes as well as the risk of other co-morbidities. Prior research by the applicant and
sponsors evaluated South Africa’s policy change in 2019 of initiating HIV treatment with a regimen containing
dolutegravir rather than efavirenz. This work demonstrated that retention and viral suppression outcomes are
similar before and after the policy change. However, this research utilized a regression discontinuity design, so
the analysis was limited to those who initiated within 3-months on either side of the date of the policy change
and further work is needed to see if this result holds once there is more experience with the new medication. In
addition, extensive access to ART in South Africa has led to people living with HIV longer. There is growing
concern that persons living with HIV, in particular those on a dolutegravir-based ART regimen, may be at
increased risk of non-communicable diseases (NCDs). However, the severity of this risk is unclear. The aim of
this proposal is to better characterize the effect of different HIV treatment strategies on retention and viral
suppression, and to address the gap in literature on the risk of dolutegravir on NCDs. Aim 1 leverages the
Target Trial Framework to assess the effect of dolutegravir treatment over 12- and 24-months on retention and
viral suppression in comparison to efavirenz over the same time period. Aim 2 will utilize sequential
randomized trials and a Target Trial Framework approach to assess, among patients initiating a treatment
regimen containing efavirenz, the effect on retention and viral suppression after switching to dolutegravir within
the first 12-months of treatment compared to remaining on efavirenz. Aims 1 and 2 will use data from a large,
prospective cohort of patients receiving care at a public health-sector clinic in South Africa. Aim 3 will assess
the effect of dolutegravir treatment on the risk of weight gain, hypertension, and type 2 diabetes mellitus in
comparison to efavirenz. Aim 3 will utilize data from clinics located in South Africa’s KwaZulu-Natal, Northern
Cape, Limpopo, Mpumalanga, and Gauteng provinces. A detailed training plan, in conjunction with these
research aims, will provide the applicant with hands-on training to support her development as an independent
infectious disease epidemiologist with expertise in NCDs and novel epidemiologic methods for observational
data. The training plan outlines mentorship opportunities provided by sponsors, who are experts in their field
and have a well-established record of collaboration and mentorship.

Public health relevance
Project Narrative HIV is a serious, chronic infectious disease, and understanding the effect of different anti-retroviral treatment strategies is critical to maintaining a person’s overall health and retention in care. Additionally, there is a growing concern that certain antiretroviral medications increase the risk of weight gain and non-communicable diseases such as hypertension, and type 2 diabetes mellitus (diabetes), but the causal effect is not well elucidated. The goal of the proposed research aims is to better understand the effects of different treatment strategies on retention in care, viral suppression, and the risk of weight gain and developing other co- morbidities.